Reflectance confocal microscopy-optical coherence tomography (RCM-OCT) imaging of oral lesions: Toward an affordable device and approach for developing countries

High rates of incidence and prevalence of oral cancers occur in 15-20 developing low-and-middle income
countries (LMICs) in Asia and Africa. Visual clinical examination followed by biopsy is the standard for diag-
nosing oral lesions. But the low and variable specificity of 16-100% of visual examinations results in biopsies
of an estimated 37-51% indeterminate lesions (1.4-2.1 million lesions in India, alone) and in benign-to-malig-
nant biopsy ratios of 2-24. Patient compliance for biopsy and follow-up care is low (35-63%) in LMIC settings
due to pain, fear, time and cost. Our novel solution is noninvasive imaging with a low-cost handheld reflec-
tance confocal microscopy (RCM) - optical coherence tomography (OCT) device. Diagnosis and grading of
oral dysplasia are based on cellular atypia in the epithelium and underlying architectural changes. RCM imag-
ing shows cellular morphology in the entire epithelium to depth of 300 µm. OCT imaging shows epithelial lay-
ers and underlying lamina propria to deeper depth of 1 mm. Combined RCM-OCT imaging with a single de-
vice will enable simultaneous imaging of cellular atypia and architectural changes in co-located fields of view to
guide diagnosis, grade dysplasia, monitor progression to malignancy and assess invasion. Stratification, with
a quantitative RCM-OCT scoring algorithm, will guide triage of oral lesions into low-grade dysplasia, which can
be monitored or immediately treated with non-surgical therapies, versus high-grade, which may be immediately
biopsied, versus carcinoma, which will be surgically excised. Diagnosis may be combined with treatment, all
integrated in a single patient visit - a “one stop shop” patient care paradigm. We are an academic-industry
team at Memorial Sloan Kettering Cancer Center (New York, NY), Physical Sciences Inc. (Andover, MA), Cali-
ber Imaging and Diagnostics (Rochester, NY) and our LMIC collaborators at Tata Memorial Hospital (TMH,
Mumbai). For FOA PAR-21-166, innovation is defined to be “likelihood of delivering a new capability to end-
users.” Innovations will be in delivering an RCM-OCT device with a new probe for intra-oral imaging and in
designing a quantitative diagnostic scoring algorithm to guide diagnosis and treatment, in real-time, at the bed-
side. The device will be delivered to TMH and will ultimately cost $25,000, when scaled up and locally manu-
factured in LMICs, which will support dissemination of RCM-OCT as a new and affordable imaging capability in
LMICs. In preliminary studies, RCM-OCT imaging detected oral lesions and cancers with sensitivity of 100%
and specificity of 80%. Our specific aims are (1) to design a handheld RCM-OCT device for imaging in the
oral cavity; (2) to prospectively test on 4,422 patients for diagnosis, grading of dysplasia and assessment of
invasion in oral lesions and cancers in vivo. Testing will be in LMIC settings, at TMH in Mumbai and in their
regional clinic in Varanasi. Affordability, delivery of care in LMICs: the return-on-investment on our device
can be in 6-9 months at cancer centers, while the cost of care to deserving patients can be as little as zero to
50 cents for the imaging procedure. Our initial success in India will seed global effort in LMICs.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Combined reflectance confocal microscopy - optical coherence tomography (RCM-OCT) imaging may noninvasively guide diagnosis of oral potentially malignant lesions and cancers, with reduced need for biopsy. The imaging in real-time at the bedside may guide diagnosis and treatment in a single patient visit – a “one stop shop” patient care paradigm. The imaging may provide care to deserving patients at low affordable costs in 15-20 low-and-middle income countries, in which high incidence rates and prevalence of oral cancer is a major healthcare problem.